Language Processing in Context Following Traumatic Brain Injury

Cognitive-communication disorder is a common and chronic consequence of moderate-severe
traumatic brain injury (TBI) and a major source of disability that is associated with negative
outcomes including reduced social participation, reduced employment, and reduced life
satisfaction. Despite intensive research efforts, no significant reduction in TBI related disability
has been documented over the past 20 years. This renewal application leverages our discovery
in the prior award period of striking deficits in language processing in context to offer a new
direction in the empirical study of cognitive-communication disorder in TBI. By determining the
underlying mechanisms and timescale of these deficits, the proposed work will provide the
necessary explanatory framework to support the future development of successful rehabilitation
efforts. At the heart of the proposed work is the new understanding that the reach of cognitive
communication disorder is more extensive affecting more aspects of language than previously
appreciated and changing in magnitude over time scales not previously examined. In showing
that cognitive-communication disorder extends considerably beyond deficits in communication
(beyond the level of the utterance in discourse and conversation) to include deficits in the real-
time processing of individual words, phrases, and sentences, the proposed work promises to
afford a richer understanding of which language processing mechanisms are impaired in TBI. In
showing that the magnitude of cognitive-communication disorder impairs the ability to learn from
communicative experiences and that deficits grow over timescales of minutes to a week, the
proposed work provides new insight into the implications of these impairments for a range of
real-world interactions and into the challenges of their clinical management. Building on these
discoveries and new methodological innovations developed in the prior award period, this
proposal is organized around three specific aims: (1) To investigate the mechanisms of the
language processing deficit in TBI; (2) To investigate the ability to learn and adapt from
language experience and use in TBI; (3) To identify the predictors of language
processing impairment at an individual level and to link impairment to functional
outcomes. The results of this research will provide the explanatory framework necessary to set
an agenda for future work developing new assessments for earlier identification and prediction
of deficits and for development of empirically based interventions. This proposal is unique in the
field and uniquely promising for understanding cognitive-communication disorder following TBI
and, ultimately, improving communication outcomes and reducing disability.

Public health relevance
Narrative Adults with traumatic brain injury (TBI) have persistent deficits in using and processing language in context, but commonly used methods to detect these deficits in clinical and research settings lack the required sensitivity which has limited progress in reducing post-TBI communication disability. Combining psycholinguistic approaches to contextual language use with ecologically valid language tasks and methods sensitive enough to detect even subtle, yet meaningful, disruptions in language, the proposed work endeavors to identity the conditions and timescales in which cognitive-communication impairments emerge (to improve characterization and identification) and the relations between deficit and participant characteristics (to improve knowledge of underlying mechanisms and predictors indicators of disability). This proposal is unique in the field and uniquely promising for understanding the nature of deficits in contextual language processing following TBI and, ultimately, improving rehabilitation intervention outcomes.